Mentalizing deficits in cocaine addiction, associations with immune dysregulation and childhood maltreatment

PROJECT SUMMARY/ABSTRACT
Building on her rich clinical background in addiction treatment, Dr. Keren Bachi, the candidate, aspires to
become a cross-disciplinary independent investigator in an area of critical importance within drug addiction:
the neuro-immune biomarkers underlying adult social cognitive function (mentalizing; the ability to
understand the mental states of others) as associated with exposure to early life stress. Drug addicted
individuals frequently experience social stress (e.g., childhood maltreatment, poverty) which may shape neural
and physiological responses to social interactions and exacerbate illness risk (e.g., craving, relapse). Training
will center on neuro-immune-environment systems approach to drug addiction, with mentorship in
neuroimaging of human addiction (primary mentor Dr. Goldstein), immune dysregulation in psychiatry (Dr.
Gabbay), neuroinflammation (Dr. Russo), advanced biostatistics (Mr. Weinberg), immunologic assessment
(Dr. Kim-Schulze), social cognition (Dr. Moeller), and mechanisms linking stress, immune adaptations, and
effects on brain function in addictive behaviors (Dr. Sinha). Goals will be accomplished through didactic
training primarily at the Icahn School of Medicine at Mount Sinai, conferences, and mainly by the study of: (I)
characterizing the behavioral and neural correlates of deficits in mentalizing in cocaine addicted individuals vs.
matched healthy controls, using a well-validated functional magnetic resonance imaging paradigm that
robustly activates the mentalizing network; (II) comparing inflammation between the two study groups, using
an immune-blood-profile previously associated with cocaine use, but here examined for the first time vis-à-vis
mentalizing and childhood maltreatment; and (III) discerning whether inflammation markers mediate the
relationships between childhood trauma with altered neural engagement/behavior during the mentalizing task.
While neuroimaging allows for spatially specific determination of brain activity, immune biomarkers enable
detection of molecular and cellular-pathways, and their join study would facilitate identification of neuro-
immune contributions to core deficits in addiction. Furthermore, testing for a contribution of biographic
adversity-history may enable the grounding of the neural and physiological findings in identifiable (and
potentially preventable) long-lasting effects of social-environmental stress. Future efforts could capitalize on
the putative mediating effects of inflammation, to develop novel treatments in drug addiction incorporating
immunomodulatory or anti-inflammatory drugs, which notably have been shown to enhance cognition in other
psychiatric patients. Enhancement of social cognition (mentalizing) could augment treatment success and
prevent relapse in addiction. Finally, social stress management interventions and prevention efforts could
potentially most optimally be deployed in those with severe childhood maltreatment. The experience, and data
gained from this study will position the candidate to pursue future NIH funding to build this line of research
and develop novel treatments in drug addiction.

Public health relevance
PROJECT NARRATIVE Cocaine use is frequently associated with experience of social stress (e.g., childhood maltreatment, low socioeconomic status) which may shape neural and physiological responses to social interactions and promote relapse. We propose to study addicted individuals’ ability to understand the mental states of others, which underlies overt behavior, and how this process may be shaped by immune-dysregulation and history of childhood trauma. A better understanding of social cognitive impairments in cocaine addiction, and particularly how they may be related to psychophysiological and social-environmental elements, may inform more effective treatment strategies, improving quality of life and reducing societal burden.